Distinguishing TLE and TLE+ using MEG virtual sensors

Project Summary/Abstract
The most common drug resistant epilepsy involves the temporal lobe (TLE) and a quarter of patients continue
to suffer from seizures after temporal lobectomy, with children designated as temporal plus epilepsy (TLE+)
having a five-times increased risk of post-operative surgical failure (continued seizures). The long-term goal of
our research program is to develop brain connectivity tools that optimize the use of targeted therapies, including
surgery. The objective of the proposed study is to use visual analysis and connectomics of MEG virtual sensor
waveforms to predict the presence of spikes on intracranial EEG (iEEG) and pre-surgically distinguish between
patients with TLE and TLE+. The central hypothesis is that user-defined virtual sensor beamforming (UDvs-
beamforming), using expert reader analysis and connectomics, are superior to ECD, current density source
modeling, and conventional beamforming for non-invasively differentiating between TLE and TLE+. The rationale
is that new, validated MEG methods would improve pre-surgical planning of iEEG and better identify patients at
risk for worsened outcomes. The research proposed in this application is innovative because (1) while MEG
connectivity measures have been studied in epilepsy, its use in pre-surgical evaluation for TLE/TLE+ would be
novel, (2) our approach can characterize both local and widespread connectivity patterns without sampling bias,
and (3) results can be collected on an individual patient basis which will facilitate immediate integration into
existing clinical pipelines. This contribution is significant because it is the first step in a program of research that
is expected to improve pre-surgical planning for patients with drug resistant epilepsy and improve understanding
of treatment failure and outcomes in epilepsy.

Public health relevance
Project Narrative This proposed research is relevant to public health because developing and validating new magnetoencephalography (MEG) methods for patients with drug resistant epilepsy will improve intracranial electrode planning for epilepsy surgery. This project is relevant to the mission of the NINDS because it is highly likely to improve surgical outcomes for epilepsy and further our understanding of treatment failure and outcomes in epilepsy.